Diversity Supplement for R00EY028964: Mechanisms of visual encoding and plasticity in anterior cingulate cortex

PROJECT SUMMARY/ABSTRACT
Unchanged from parent grant.

Public health relevance
NARRATIVE Unchanged from parent grant.